Understanding the effects of gestational fentanyl exposure on external morphology, neonatal opioid withdrawal, and brain volume, morphology and neurochemistry of offspring

Abstract / Project Summary
The opioid epidemic has impacted the lives of millions of individuals, including women that use opioids,
such as fentanyl, during pregnancy putting the fetus at risk. A shocking NBC news story in late 2023 reported
on a clinical case study that indicates a novel syndrome in babies exposed to fentanyl during pregnancy may
have been found. However, polysubstance use in humans often complicates research, which may be the case
here; therefore, an urgent need exists to determine the effects of gestational exposure to fentanyl (alone) on
offspring well-being. In response to this need, we propose a set of studies using a rodent gestational exposure
model to measure the effects of fentanyl during pregnancy on offspring at birth through early development. Our
central hypothesis is that gestational fentanyl exposure causes malformation of the body and brain and abnormal
behavior in offspring. We will test this hypothesis by determining the impact of gestational fentanyl exposure on
morbidity and mortality, developmental milestones, external morphology, blood cholesterol, brain morphogen
signaling, and neonatal opioid withdrawal and related behavioral measures in offspring. Furthermore, we will
determine the impact of gestational fentanyl exposure on brain volume, morphology, and neurochemistry of
offspring using magnetic resonance imaging and spectroscopy in vivo. The results of these studies will directly
impact the clinical situation and our understanding of the direct role of gestational exposure to fentanyl in the
reported cases indicating that a newly discovered fetal fentanyl syndrome may exist.

Public health relevance
Project Narrative Due to the opioid crises in the United States, many pregnant women are using opioids, including the synthetic and highly potent opioid fentanyl that has recently been associated with possible fetal malformations. Fentanyl exposure during pregnancy may alter fetal morphology and brain development resulting in a new fetal fentanyl syndrome, similar to fetal alcohol spectrum disorder. However, complex human use patterns make it difficult to assess the exact consequences of this unique opioid on offspring well-being. Thus, our translational rodent model will illuminate the effects of gestational fentanyl exposure on body, face, and brain morphology, neonatal opioid withdrawal behaviors, and brain structure and neurochemistry of offspring using state-of-the-art neuroimaging techniques and will thus help address possible teratogenic effects of fentanyl. The resultant findings, in turn, may help mitigate adverse health outcomes of infants exposed to fentanyl during pregnancy.